Implementation and Dissemination of Evidence-Based Interventions to Improve PrEP Care Continuum Outcomes Among Women in Community Health Clinics in the Southern U.S.

Significant geographic differences in HIV incidence exist in the United States, with people in the Southern United States having disproportionately high rates of HIV infection yet low rates of PrEP utilization. Through preliminary work, we have identified successful strategies to increase PrEP uptake and support PrEP persistence among patients in community health clinic settings. Using the Exploration, Preparation, Implementation, and Sustainment (EPIS) implementation science framework, this proposal will adapt these strategies for implementation and scale up in the Southern United States to improve PrEP care continuum outcomes among patients.

Public health relevance
In the Southern United States, there is a high incidence of HIV yet low rates of pre-exposure prophylaxis (PrEP) use for HIV prevention. There are several challenges to engaging patients in the PrEP care continuum, such as difficulty identifying patients at highest risk for HIV who are most likely to benefit from PrEP, inaccurate self-perception of HIV risk, low levels of PrEP knowledge, and barriers to PrEP initiation and persistence. No single intervention or strategy has been shown to address these multi-level barriers across different healthcare settings and geographic regions. Consequently, there is a need to identify and implement successful strategies to increase PrEP uptake and support PrEP persistence among patients in various settings throughout the United States. Through preliminary work, our team has identified a set of effective strategies for increasing PrEP uptake and supporting PrEP persistence in a community health center setting in the Midwestern United States. The strategies include 1) routine PrEP education for patients, 2) standardized provider training, 3) electronic medical record optimization tools for identifying patients who would benefit from PrEP and tracking PrEP outcomes, and 4) PrEP navigation. Although these strategies were successful within this setting, they have not yet been studied in other healthcare settings or community health centers outside of the Midwest. Therefore, we propose to refine, implement, and evaluate the impact of an intervention to improve PrEP care continuum outcomes for patients in the Southern United States, using implementation science research methods. Guided by the Exploration, Preparation, Implementation, and Sustainment (EPIS) implementation science framework, we will undertake the following aims: 1) Preparation and Adaptation: Adapt previously identified successful implementation strategies for engaging patients in the PrEP care continuum in a Midwestern community health center for use in a Southern community health center. 2) Implementation and Evaluation: Via a hybrid type II design using the Reach, Effectiveness, Adoption, Implementation, and Maintenance (RE-AIM) framework, measure the implementation and effectiveness outcomes of the adapted interventions in the Southern United States compared to the approach in the Midwestern United States. We will complete a stepped-wedge cluster randomized trial in 12 community health centers in the Midwest and South. 3) Sustainment and Spread: Develop an implementation guide that can be utilized across Southern U.S. jurisdictions to improve PrEP care continuum engagement among patients, reflecting the knowledge gained through adaptation. This will allow for rapid dissemination and replication of these strategies to improve PrEP care continuum outcomes among patients throughout the United States.